Developmental/Pilot Project Program p280-287

Program Director/Principal Investigator (Last, First, Middle): Hornik, Robert & Lerman, Caryn - Developmental/Pilot Project Program DEVELOPMENTAL/PILOT PROJECT PROGRAM DESCRIPTION A. OVERVIEW AND AIMS The University of Pennsylvania (UPENN) TCORS Developmental/Pilot Project will stimulate and promote high- priority innovative projects responding to emerging scientific questions from the Penn TCORS and enable a rapid response to new developments in the scientific and regulatory communities at large. This program follows the successful operating model of the pilot research programs in the NCI Penn Center of Excellence in Communication Research (CECCR) and Center for Interdisciplinary Research on Nicotine Addiction (CIRNA). This established infrastructure includes mechanisms to: solicit pilot projects; review and support pilot projects; evaluate the success of funded projects and the program overall; and foster the development of new grant applications for the most promising pilot projects. The developmental projects also provide opportunities to involve researchers with varied disciplinary backgrounds, apply new research technologies, and foster new collaborations in the area of tobacco research of relevance to the FDA. Although we anticipate that most within-Center pilot projects would relate to the Center's theme of